Molecular Approaches to Vaccines and Immune Monitoring

ABSTRACT Support is requested for a Keystone Symposia conference entitled Molecular Approaches to Vaccines and Immune Monitoring, organized by Drs. Peter D. Kwong, Brandon DeKosky, and Jeffrey B. Ulmer. The conference will be held in Keystone, Colorado from February 10-14, 2019. Vaccines address public health issues ranging from pandemic outbreaks to childhood disease. Despite this diversity, molecular approaches are beginning to find broad application. This Keystone Symposia conference seeks to bring together antibody aficionados, B cell immunologists, structural biologists, and vaccine developers from government, academia, biotechnology, and major pharmaceutical companies to review the utility of structure-based vaccine design and antibody-based immune monitoring, and in doing so hope to transform standard approaches of vaccine development. This meeting aims (1) to provide examples of the “antibody-to- vaccine” paradigm for RSV, CMV and other pathogens that have resisted standard vaccinology; (2) to describe procedures whereby B cells can be taught to make the right antibodies; (3) to describe molecular approaches for vaccine improvement; and (4) to discuss how molecular approaches can be used to speed development (as may be needed, for example, in the case of pandemics) and to reduce developmental and regulatory costs (for vaccines in general and in particular to enable provision to the developing world). Overall, we seek to integrate molecular approaches for vaccine development and read-out with other transformative advances including mRNA delivery, next-generation sequencing of B cell transcripts, and control of B cell-T cell interactions. This conference will be held jointly with a Keystone Symposia conference on B Cell-T Cell Interactions and several shared sessions will highlight synergistic areas of research between these communities.

Public health relevance
PROJECT NARRATIVE Vaccines are without question one of our most effective medical interventions addressing numerous public health issues, from pandemic outbreaks to childhood diseases, and yet many major challenges remain, including improving existing but suboptimal vaccines, addressing unmet medical needs and responding rapidly to newly emerging infectious diseases. To this end, molecular approaches are beginning to find broad application, especially against pathogens that have resisted standard approaches to vaccine development. The conference will occur at a time when the first structure-based vaccines developed from antibody templates are making clinical headway against pathogens such as respiratory syncytial virus (RSV) and cytomegalovirus (CMV) that have long-resisted vaccine development.